MICROCHIMERISM AND THE DEVELOPMENT OF CORONARY ARTERY VASCULOPATHY

This project in heart transplant recipients will study effects of concomitant bone marrow transplant and subsequent development of transplant arteriopathy.